Epigenetic regulation of kidney regeneration

PROJECT SUMMARY
The goal of this K08 Career Development Award proposal is to provide training for Elizabeth Nguyen, MD,
PhD, as she establishes her career as an independent academic investigator in the fields of epigenetics and
kidney regeneration. As a pediatric nephrologist, Dr. Nguyen helps patients navigate the progression of kidney
injury to chronic kidney disease, an irreversible process resulting in immense burden for these families and the
healthcare industry. As there is currently no treatment to reverse injury to a fibrotic kidney, her research
interest is to identify mechanisms that promote kidney regeneration. To achieve this goal, she is training under
the mentorship of Dr. Mark Majesky, whose lab identified that the African spiny mouse evolved the ability to
exhibit scar-free kidney regeneration after kidney injury. With her research experience in computational biology
and genetics, Dr. Nguyen determined that kidneys of the spiny mouse express the same proteins as the house
mouse, but its response to injury is remarkably different, indicating that epigenetic control of gene expression
may be the key to its regenerative capabilities. She generated a fully annotated reference genome for the spiny
mouse which enables the epigenomic interrogations she proposes. Her central hypothesis for this proposal is
that histone modifications in spiny mice proximal tubular epithelial cells activate gene regulatory networks that
promote kidney regeneration in response to ischemic injury. The aims of this proposal will 1) define proximal
tubule cell states during kidney regeneration in the spiny mouse, 2) construct gene regulatory networks
controlling proximal tubule cell regeneration in the spiny mouse and 3) identify mechanisms critical for kidney
regeneration in the spiny mouse, examining the role of the Yap-TEAD pathway as it undergoes histone
mediated activation in the spiny mouse kidney as presented in her preliminary data. To achieve these aims,
the applicant proposes a career development plan that allows her to gain advanced skills in epigenetics,
regeneration biology and models of kidney injury. She has assembled a mentoring team of nationally
recognized experts with a history of training successful investigators including her primary mentor, Dr. Mark
Majesky (African spiny mice regeneration), and committee members Dr. David Beier (epigenetics of kidney
disease), Dr. Steven Henikoff (chromatin profiling methods), Dr. Samir El-Dahr (epigenetics of kidney
development), Dr. Shreeram Akilesh (multiomic investigations of kidney injury) and Dr. Hannele Ruohola-Baker
(stem cell and regenerative biology). Her training will be complemented by coursework, conferences, and
faculty development programming. Her research will be performed at Seattle Children’s Research Institute
where key resources include a colony of spiny mice and state-of-the-art genomic technology. Achieving these
aims will provide the foundation necessary for her to construct a competitive R01 proposal. Through this
proposal, Dr. Nguyen will be well prepared for an independent research career aimed at understanding the
epigenetic regulation driving mechanisms of kidney regeneration.

Public health relevance
PROJECT NARRATIVE Repeated episodes of kidney injury often result in progressive and irreversible scarring and loss of function. This application seeks to investigate mechanisms for kidney tissue regeneration by understanding how gene expression is regulated by epigenetic changes in the African spiny mouse, an animal model that can regenerate kidney tissue after injury.